CORE--Clinical Trials Office

DESCRIPTION (provided by applicant): The Clinical Trials Office of the UNMC Eppley Cancer Center participates in the activation and conduct of clinical cancer research at the Cancer Center. This includes assistance with protocol development, coordination of initial and periodic reviews submitted to the Institutional Review Board, data coordination and collection, and coordinates supervision of appropriate clinical trials by the Audit Committee and the Data and Safety Monitoring Committee. Since the last review (7/1/99 through 6/30/03), a total of 3171 patients have been entered onto Cancer Center clinical research protocols, of which 1054 patients have been entered onto therapeutic trials and 2117 patients were entered onto correlative clinical research studies, companion studies, and chemoprevention clinical research protocols. During the past four years (7/1/99 - 6/30/03) 385 patients were entered onto investigator-initiated clinical trials. During the past year (7/1/02 - 6/30/03), 41 Cancer NCI-A 40 2 P30 CA036727-20 COWAN, K Center members have utilized this facility, of which 26 had external funding, and 156 clinical research protocols were open to accrual during this period. In the last year (7/1/02-6/30/03), 558 patients were entered onto Cancer Center clinical research protocols, of which 310 patients (or 56% of the total patients) were entered onto therapeutic trials. Over the last year, the Cancer Center has undertaken several initiatives to enhance clinical research activities by increasing the support of the administration of the Clinical Trials Office, consolidation of the administrative staff of Clinical Trials Office in a central location in the Lied Transplant Center and the establishment of a Data and Safety Monitoring Committee.